Development of a sensitive method to measure heparan sulfate 6-O-endosulfatase

The proposal is aimed to develop a sensitive method to measure the activity of heparan
sulfate 6-O-endosulfatase (SULF). SULF is an enzyme that removes the 6-O-sulfo
groups from heparan sulfate polysaccharides to modulate the functions of heparan
sulfate. Evidence has demonstrated that the level of SULF contributes to the
progression of cancers; however, the method that measures the activity from biological
sources is lacking. In this phase I SBIR proposal, we propose to use a LC-MS/MS
method to determine the activity from plasma and solid tissues. The crucial innovation is
that we will use structurally homogeneous heparan sulfate oligosaccharides as
substrates to address the issue for the selectivity of the measurement. In addition, we
plan to use 13C-labeled oligosaccharide substrates and coupled with disaccharide
analysis using a LC-MS/MS, which is expected to increase the sensitivity and add
quantitation capability. Aim 1 is designed to find the optimal oligosaccharides for purified
SULF enzyme, demonstrating the feasibility of using oligosaccharides to measure the
activity of SULFS, including both SULF-1 and SULF-2. We plan to test different
oligosaccharides in the size ranging from hexasaccharide (6-mer) to octasaccharide (8-
mer). Aim 2 is improve the quantification accuracy using 13C-labeled HS oligosaccharide
substrates and LC-MS/MS. Here, we plan to use 13C-labeled oligosaccharide substrate
in the analysis. The use of 13C-labeled substrate will eliminate the interference from
endogenous HS. Instead of directly measuring de-sulfated oligosaccharide, we plan to
degrade the 13C-labeled oligosaccharides into disaccharides using heparin lyases
followed by LC-MS/MS analysis. We expect that disaccharide analysis will significantly
increase the sensitivity compared to the measurement of intact oligosaccharides,
offering a sensitive and quantitative method to measure the activity of SULF from
tissues and plasma. In the phase II analysis, we plan to expand the analysis to a wide
range of cancer tissues. The success will lead to a necessary tool for glycoscience to
investigate the roles of heparan sulfate in cancers.

Public health relevance
Project Narrative Heparan sulfate 6-O-endosulfatase is a key enzyme that modifies the structure of heparan sulfate polysaccharides. Evidence shows that the level of 6-O-endosulfatase relates to various cancers. In this project, Glycan Therapeutics plans to develop an innovative method to determine the activity of 6-O-endosulfatase. The success of the project will provide a new tool to study the role of heparan sulfate in cancers and develop a biomarker for cancer diagnosis.